Aerosolized Vitamin A: Developing a Prevention for Hyperoxic Lung Injury and Bronchopulmonary Dysplasia, with Focus on Neonatal Lung Maturation

Advent Therapeutics (Advent) is a biotech focusing on novel approaches to reformulate and optimize delivery
of legacy drugs with proven efficacy to address unmet medical needs of specific underserved and orphan patient
populations. Advent is developing an aerosol formulation of its proprietary, optimized water miscible vitamin A
(vitA) palmitate for non-invasive (inhaled) delivery to preterm infants to address vitA deficiency (VAD), and
prevent bronchopulmonary dysplasia (BPD), its most serious and costly complication. Prevention of BPD is the
focus of this Phase IIB/SMA application and a NHLBI topic of specific interest under this FOA, RFA-HL-23-008.
We will be building on the very significant data supported by our Phase I/II SBIR award with our innovative
inhaled vitA formulation that: 1) avoids the drawbacks of invasive intramuscular (IM) injections and absorption
limitations of current oral forms, overcoming significant hurdles for routine NICU utilization, and 2) provides direct-
to-target-organ delivery for increased efficacy- our in vivo data show significant benefit over IM dosing in
mitigating hyperoxic lung damage (in our BPD animal model), while providing adequate systemic delivery to also
treat VAD as discussed in the Research Strategy and in our recent publication (47).
In collaboration with Dr. Virender Rehan at Harbor-UCLA Medical Center, we have completed all Phase I
Specific Aims and are wrapping up Phase II Aims, demonstrating that inhaled vitA: 1) stimulates lung maturation
(assay of lung biomarkers showing upregulation of retinol receptors, surfactant protein and phospholipid
synthesis, as well as maturation biomarkers, while simultaneously raising serum vitA levels similar to IM dosing);
2) dramatically (vs IM) reduces hyperoxic lung tissue damage (assessment of lung tissue histomorphometry and
reduction of lung-injury biomarkers); and 3) preserves pulmonary function (preliminary longer-term PFT data).
In Phase IIB, we will further refine inhaled vitA dosing strategies for mitigating hyperoxic lung damage (BPD
prevention) in a step-wise approach by studying the well characterized premature lamb BPD model and proceed
with IND-enabling activities to be ready to begin first-in-man clinical studies in preterm infants at risk for
development of BPD. Phase IIb Specific Aims are: 1: Optimization of the dosing regimen of aerosolized vitA
for mitigating hyperoxic lung damage in a premature lamb BPD model, focusing on both the “neonatal” (acute
phase) timeframe, and also over the longer term (chronic phase) into “adulthood”, assessing similar biomarkers,
morphologic, and PFT evaluation as per Phase I/II. Aim 2: proceeding with drug manufacturing development
and scale-up of our formulation under stringent GLP and GMP controls. Aim 3: conducting GLP toxicology
studies in both small (rat) and large (dog) species to support clinic-readiness. Measures of success will be
generation of data supporting further development of our novel non-invasive therapy for preventing BPD (and
treating VAD), including a vitA formulation that meets adequate CMC requirements to proceed into the clinic,
and completion of GLP toxicology showing adequate safety for first-in-man studies in at-risk preterm neonates.

Public health relevance
The consequences of inadequately treated vitamin A deficiency (VAD) in premature neonates includes increased risk for bronchopulmonary dysplasia (BPD), which is associated with poor clinical outcomes in these fragile patients and requires costly long-term care. Advent Therapeutics is developing an aerosol formulation of its proprietary optimized, water miscible vitamin A palmitate (vitA) for non-invasive delivery of the drug to preterm infants, enabling dosing via inhalation and thus obviating the need for intramuscular (IM) injection; direct delivery to the lung (a direct-to-target-organ treatment for BPD) should increase effectiveness, while simultaneously providing systemic vitamin A availability, important for treating VAD and its related complications (not only BPD, but also retinopathy of prematurity (ROP) and sepsis). Dosing vitA by inhalation should overcome current hurdles limiting vitamin A supplementation use in the NICU, enabling much higher vitamin A utilization, with potential to decrease risk and cost of BPD in preterm infants.